IGF::OT::IGF SCG Labor for Audiovisual support for 10th Annual Conference on the Science of Dissemination and Implementation

Labor for Audiovisual support for 10th Annual Conference on the Science of Dissemination and Implementation